Implementation Intervention to Improve Care for Unhealthy Alcohol Use

Background. Alcohol use is a significant risk factor of disability and death for U.S. adults and one out of every
six Veteran seen in primary care (PC) report unhealthy alcohol use. Unhealthy drinking is associated with
increased risk for poor medical outcomes, substantial societal costs, and death, including suicide. Based on
substantial evidence from randomized controlled trials and the U.S. Preventive Services Task Force, VA/DoD
clinical guidelines stipulate that all Veterans screening positive for unhealthy alcohol use should receive
evidence-based alcohol care in PC, including brief counseling interventions (BI) and additional treatment (e.g.,
pharmacotherapy) for those with alcohol use disorders (AUD). The VA was a pioneer in implementing alcohol
screening and BI in PC, yet substantial implementation gaps remain. Approximately 25% of Veterans with
unhealthy alcohol use still do not receive BIs and evidence suggests that the quality of BIs is lacking. For those
with AUD, BI implementation has not appeared to increase access to recommended services (e.g., referrals) nor
reduced barriers to pharmacotherapy. In order to improve the quality and fidelity of alcohol-related care, the
current research proposes to use an evidence-based implementation strategy, practice facilitation, at one VA to
pilot test whether practice facilitation has the potential to improve quality of PC-based alcohol-related care.
Significance/Impact. This research directly addresses one of the largest public health crises of our time, as
alcohol kills more people than opioids and is associated with increased risk of suicide. Thus, this work may have
far-reaching effects on adverse outcomes experienced by Veterans and is aligned with top HSRD and VA
priorities, including increased access to care and suicide prevention. Innovation. The project will use innovative
implementation techniques not previously used to improve VA alcohol-related care. Specific Aims. Aim 1 is a
qualitative study assessing Veteran and PC stakeholders to understand barriers and facilitators to high-quality
alcohol care and use results to refine and hone the practice facilitation intervention. Aim 2 will deliver the practice
facilitation intervention in a small PC sample to examine its acceptability and feasibility. Aim 3 is a pilot test of
the practice facilitation intervention in the full PC clinic to understand whether practice facilitation improves quality
of PC-based alcohol-related care. Methodology. Aim 1 will recruit and interview Veterans with unhealthy alcohol
use (n=20-25) and PC stakeholders (N=10-15) to help refine the practice facilitation. Aim 2 will deliver the
practice facilitation among a small sample of PC providers and staff (n=5-7) to assess acceptability/feasibility. In
Aim 3, PC providers/staff from the full clinic will be invited to participate in the practice facilitation in order to
assess implementation (e.g., reach) and effectiveness (reduced drinking) outcomes. Implementation/Next
Steps. Findings will be presented to local and national operational partners and used to improve evidence-based
alcohol-related care nationally across VA PC. Candidate. Dr. Rachel Bachrach is a clinical psychologist and
postdoctoral research fellow in the Interprofessional Advanced Fellowship in Addiction Treatment based within
the Center for Health Equity Research and Promotion (CHERP), a VA HSR&D Research Center of Excellence.
The purpose of this CDA-2 is to facilitate Dr. Bachrach’s transition to an independent HSR&D investigator with
a long-term objective of improving evidence-based care for addictive disorders. The short-term objective is to
obtain formal training, expert mentorship, and research experience to facilitate a VA HSR&D career focused on
improving prevention and intervention efforts within PC for Veterans who screen positive for unhealthy alcohol
use. Mentorship will provide focused training on goals relevant for both the current CDA-2 research project and
for Dr. Bachrach’s career as an independent scientist, including in-depth training in (1) implementation science;
(2) alcohol-related care; (3) qualitative methods for intervention development; and (4) intervention design and
evaluation.

Public health relevance
Unhealthy alcohol use is common among Veterans and a significant risk factor for numerous negative health consequences, including chronic disease, injury, mortality, and suicide. It is also linked to increased financial and societal costs (e.g., higher healthcare utilization, criminal justice expenses). Due to these burdens, effective, evidence-based care for Veterans with unhealthy alcohol use was implemented in VA primary care settings. However, significant gaps in this care have been identified, indicating that a substantial proportion of Veterans in need of help are not receiving it. Improving the implementation of alcohol-related care in primary care settings has the potential to increase access to both preventive care (e.g., brief counseling interventions) and treatment (e.g., medications for alcohol use disorder), thereby significantly decreasing the harmful health and societal consequences associated with drinking.